Linking Mycobacterium Tuberculosis infection outcomes with transcriptional networks in genetically diverse mouse macrophages

Project Summary:
Tuberculosis (TB), like many infectious diseases, demonstrates striking variation between individuals in its
clinical manifestation. People infected with the causative agent, Mycobacterium Tuberculosis, range in disease
state from completely asymptomatic infection to life-threatening disseminated disease. Even though many
infected individuals do not develop symptoms and most resolve the infection with treatment, TB is perennially
the leading cause of death by a single infectious agent with an annual death toll of more than one million people.
A major goal of TB research is to understand the basis of the variability in infection outcomes. Such an
understanding will help in identifying ways to improve treatments and tip the scale away from pathological
inflammation lung damage toward healthy resolution of infection. One important factor that contributes to the
outcome of TB is the genetic background of the infected individual. Many studies have addressed the role of
natural genetic variants in determining TB outcomes in both humans and mice. However, relatively few studies
have investigated these associations in the context of macrophages, a central cell type of interest in TB. This
project will explore the relationship between genetic variants, transcriptional responses, and Mtb infection
phenotypes in macrophages derived from genetically diverse Collaborative Cross (CC) mice. In preliminary
studies, I associated variants in the Stat2 locus with the strength of type I interferon signaling in stimulated CC
macrophages. Therefore, I hypothesize that polymorphisms, such as those in Stat2, underlying variation in
transcriptional responses are responsible for heterogeneity in bacterial control in CC macrophages. I will test
this hypothesis using a novel tool developed to specifically investigate the role of natural genetic variation in
determining macrophage phenotypes. This hypothesis will be tested in three specific aims which will both
generate novel genetic association and determine the mechanism of previously identified associations. I will use
an exploratory approach in the first aim to discover what the genetic and transcriptional determinants of Mtb
restriction are in this population of macrophages. This approach is likely to discover novel mechanistic insights
into how macrophage respond to Mtb infection. In the second and third aims, I will delineate the mechanism by
which polymorphisms in Stat2, a mediator of type I interferon signaling, alter its function. The second and third
aim will test an updated model of the recognition of DNA by STAT2 which I generated by combining macrophage
genetic association studies and structural modeling. In the proposed studies, I will utilize and continue to develop
an innovative new tool, the CC macrophage library. I will incorporate genetic, biochemical, and systems
approaches to discover and characterize associations of polymorphisms and transcriptional networks with Mtb
infection outcomes. The results of these studies will provide insight into innate immune processes and will be
important to consider for future studies into TB and other infectious diseases using the Collaborative Cross.

Public health relevance
Project Narrative Macrophages are essential for tissue surveillance and response to infectious diseases, particularly Tuberculosis where these cells also serve as a niche for the bacterium. This project will investigate the macrophage response to infection with Mycobacterium Tuberculosis in both a broad survey of the genetic and transcriptional determinants of infection outcome and a finely detailed mechanistic study of a key transcription factor in the innate immune response. The findings of this study will improve our understanding of innate immune processes that are directly relevant to Tuberculosis pathogenesis and also will have implications in viral, bacterial, and autoimmune pathologies.